Molecular and metabolic characterization of gut stromal cells underpinning efficient intestinal B cell response

Abstract
The humoral immune response at the intestinal interface has evolved to control commensal communities and
prevent entry of pathogenic microbes and toxins. B lymphocytes in the gastrointestinal tract are constantly
stimulated by microbial antigens and are geared toward generation of immunoglobulin A (IgA), which is the
main antibody isotype found in the intestine. B cells mount a rapid antibody response against bacteria via
germinal center reaction, a complex multistep process of B cell proliferation and selection, which leads to the
generation of antibody-secreting plasma cells or memory B cells.
Central for the germinal center reaction are Follicular Dendritic Cells (FDCs), specialized stromal cells that
play a crucial role in displaying antigens to germinal center B cells.
While our knowledge of how germinal center B cells develop, survive and function has increased exponentially
thanks to the generation of specific genetic model, a detailed, mechanistic map of FDC functions during
germinal center reaction in response to intestinal commensals and oral vaccination has not been charted yet,
mainly because experimental tools to study FDCs are not available.
Several lines of evidence indicate that FDCs play multiple role in organizing B cell response, both via secreted
and membrane-bound molecules. In the gut, cells are exposed to multiple environmental cues, so it is
conceivable that FDCs might integrate those signals to tune germinal center reaction and IgA response. Yet,
the exact mechanistic contribution of FDCs in mounting IgA response remains elusive.
In this application, we will generate a novel, inducible Cre mouse to specifically target FDCs. This approach
relies on a binary Cre approach therefore increasing specificity. We will test the hypothesis that FDCs are
essential for maintenance of IgA titer and continuous humoral response to commensal, toxins and enteric
pathogens. We also hypothesize that intracellular and extracellular receptors signaling in FDC is essential to
coordinate germinal center reaction and tune proper generation of memory B cells and plasma cells.
Our aims are: 1) to develop a FDC inducible split-Cre model, and 2) to dissect metabolic and molecular
sensing by FDCs in the intestine. The proposed studies will rigorously examine the role of FDCs on
generation and maintenance of intestinal humoral immunity. It is our expectation that these studies will
increase our understanding of how intestinal antigen display shapes B cell response and adaptive immunity.
Furthermore, these studies will provide a transformative tools for better understanding of the relationship
between FDCs and B cell response in the gut across time and states.

Public health relevance
Narrative Intestinal humoral response, which is dominated by the production of immunoglobulin A (IgA), requires B cells to be activated by antigens and to form germinal center reaction, IgA-secreting plasma cells and IgA-expressing memory B cells are generated. Critical for the germinal center reaction are a subset of radio-resistant stromal cells called follicular dendritic cells (FDCs): this proposal aims to elucidate the role of FDCs in controlling IgA response generation and maintenance, and to map FDCs cellular and metabolic processes that integrate environmental signals and coordinate B cell response in the gut. Data generated from this proposal will produce accurate insights into FDC-centered activation of B lymphocytes in the intestine during both homeostasis and enteric infection.